COBRE for Restoration of Neural-Based Function

OVERALL – PROJECT SUMMARY / ABSTRACT
The COBRE in Stroke Recovery has been tremendously successful – effectively establishing the Medical
University of South Carolina (MUSC) as an international leader in stroke rehabilitation research, with outstanding
researchers and core resources. Our Phase 3 strategy is to remain leaders in stroke recovery while widening
our scope to fully support research into the restoration of neural-based function in all populations – building upon
the diverse and multidisciplined user base built over the first two phases – effectively becoming the COBRE for
Restoration of Neural-Based Function. The COBRE will foster continued innovation; technology development;
and diverse and multidisciplinary faculty recruitment, career development, and retention. Further, we propose to
fully align our COBRE investigators and core infrastructure with three synergistic MUSC strategic research
initiatives. Our Specific Aims are to: 1) Optimize successfully established stroke recovery research programs
and restoration of neural-based function infrastructure built in prior COBRE phases; and 2) Implement strategies
to advance MUSC research excellence in the restoration of neural-based function beyond COBRE funding. First,
we will streamline existing Phase 2 cores to better serve the needs of our investigators by refocusing on specialty
services not available elsewhere, while transitioning those services which have become more widely available
through other university research cores. Specifically, we will consolidate the specialty services of the Brain
Stimulation and Neuroimaging Cores to become a more focused Neural Function Core supporting
neuromodulation, neural recordings, and combined multimodal studies. Second, we will coalesce COBRE
operations and human capital within a newly constructed research home. This will create a truly synergistic
research environment for transdisciplinary collaboration to tackle complex restoration of neural-based function
research in state-of-the-art laboratories. Next, we will leverage considerable, new university-wide faculty growth
and diversity programs – in which COBRE faculty already have leadership roles – to accelerate cluster hiring,
career development, and resource allocation for sustained COBRE growth and independent operations post NIH
funding. Finally, we will support a robust pilot project program to drive novel mechanistic and technological
innovations. MUSC will be leaders in ushering in the era of neural circuit-based medicine as we use our world-
class resources to develop novel neuromodulation interventions for restoring neural-based functions across the
spectrum of physical function, cognitive function, and psychiatric function for all of those in need.

Public health relevance
OVERALL – PROJECT NARRATIVE Stroke and other neurological conditions are leading causes of disabilities and healthcare expenses in the US. The vision of the COBRE for Restoration of Neural-Based Function is to be a self-sustaining leader in stroke and neurological recovery and rehabilitation research through world class scientific resources, accessible training programs, and new multidisciplinary faculty hires.